Program for AIDS Clinical Research Training (PACRT)

Project Summary
Over the past 40 years, dramatic advances in the understanding of HIV infection and its therapy have
transformed HIV into a highly treatable, chronic disease. Along with this evolution, critical questions have
arisen about how basic research and clinical trials can best be linked to clinical epidemiology and outcomes
research, both in the U.S. and internationally. The goal of the Program for AIDS Clinical Research Training
(PACRT) — which has successfully trained multiple generations of leading HIV clinical investigators for the
past 30 years — is to provide training in quantitative research methodologies with a focus on HIV clinical
research to pre-doctoral PhD students and physician investigators at the most formative stages of their
careers. This training has prepared both groups to conduct clinical research of the highest quality and of direct
relevance to the prevention and treatment of HIV infection. These young investigators have made important
and substantive contributions to the scientific literature and to HIV clinical care and policy, and a large majority
have developed into successful independent investigators. In the next grant cycle, the PACRT trainees will
receive two years of research training under the close supervision and mentorship of one or more of the 14
diverse and experienced program faculty members. Trainees will receive didactic training at the Harvard T.H.
Chan School of Public Health or other Harvard University sites. Primary performance sites for the five post-
doctoral fellows will be the Massachusetts General Hospital, Beth Israel Deaconess Medical Center, Brigham
and Women's Hospital, Boston Children’s Hospital, and Harvard Medical School. The primary site for the two
pre-doctoral fellows will be the Harvard T.H. Chan School of Public Health.
This program has three specific aims for its trainees:
1) To acquire a sufficient body of knowledge of quantitative methods to conduct independent research
in: clinical epidemiology, outcomes research, implementation science, cost-effectiveness analysis,
and/or clinical trials in HIV.
2) To foster the creation of important scientific contributions with the close and longitudinal mentorship
of program faculty.
3) To develop a primary research focus and broad understanding of the various aspects of HIV disease
for novel interdisciplinary investigation, leading to a successful career focused on HIV research.

Public health relevance
Project Narrative The PACRT continues to have a clearly defined and unique direction among HIV T32 programs, with its focus on clinical outcomes research, and how that research interfaces with translational research, clinical trials, and health policy. The program plays a crucial role in training the next generation of highly successful investigators to address the complex and evolving issues arising today in HIV clinical research.